Enduring Consequences of Chronic Repeated Stress on Neuro-Metabolic Function

Project Summary
While neurocognitive disorders are becoming more prevalent within America’s aging populations, mood
disorders are steadily being diagnosed at younger ages each year. The positive correlation between adverse
childhood experience and the development of disorders including, depression, anxiety, and Alzheimer’s
disease, suggests a crucial connection between trauma and long-lasting neurological changes. Previous focus
has been on the impact of early life stress and the subsequent changes in the brain, however little focus has
been placed on repeated trauma that begins in, and continues throughout, the highly dynamic and unique
developmental period of adolescence into early adulthood. The combination of hormonal surges and peak in
more severe trauma and abuse undoubtedly shapes the neural landscape. Moreover, the aforementioned
disorders demonstrate sex-specific shifts that are heavily linked to the shift in hormone concentration
circulating throughout the body during this period. The classification of stress as a metabolic disorder and the
strong connection between sex hormones, mitochondrial function, and sex-specific alterations in the
hypothalamic-pituitary-adrenal axis following chronic stress (CS) have been topics of increased discussion.
Therefore, it is of utmost importance to explore the relationship between these factors and potential
mechanistic differences between the sexes. Data from the literature suggests that chronic activation of the
HPA axis in male rodents alters the mitochondrial genome and may change synaptic mitochondrial respiration
and mitochondrial membrane permeability. Preliminary data suggests increased mitochondrial respiration in
whole brain synaptosomes of females but not males following CS. Using male and female C57Bl/6 mice
subject to 15 consecutive days of chronic repeated predation (CRPS) stress during adolescence and another
15 consecutive days during early adulthood, this proposal aims to assess persistent changes within synaptic
mitochondrial respiration of the hippocampus (HPC) following trauma. Mitochondrial oxidative phosphorylation
will be measured from HPC synaptosomes to assess region specific stress- and sex effects. Measurement of
mitochondrial ERβ and UCP2 will provide foundational evidence to begin developing a mechanism explaining
these changes. The overarching goal of this proposal is to determine the effect of CRPS in the alteration of
metabolic function in HPC neurons and mitochondrial Erβ and UCP2 expression in a sex- and stress- specific
manner. Resulting data will support the claim that CS during this critical timepoint promotes persistent, sex-
specific changes subsequently increasing the risk of psychological disorders and neurodegeneration.
Understanding the link between chronic repeated trauma and subsequent alterations in both brain and
behavior in adulthood may aid in the identification of high-risk individuals, aid in the early detection of cognitive
decline, and assist in the development of the neural mechanisms to be used in the development of novel,
preventative treatments for both mood and neurodegenerative disorders to advance mental healthcare.

Public health relevance
Project Narrative Evidence suggests stress during the highly sensitive neurodevelopmental period of adolescence and early- adulthood may decrease electron transport chain derived ATP production through the dysregulation of the hypothalamic-pituitary-adrenal axis, subsequently decreasing complex V activity by way of estrogen receptor ß and disrupting the mitochondrial proton gradient by way of increasing UCP2 within mitochondria at the synapse, priming the brain for neurodegeneration in a sex-specific manner weeks after the stressor has been removed. The overarching goal of this proposal is to determine the effect of chronic repeated predation stress in the alteration of metabolic function in hippocampal-derived synaptosomes and to determine a mechanism explaining the observed change in synaptic mitochondrial function. Resulting data will support the claim that chronic stress during this critical timepoint promotes persistent, sex-specific changes that occur first within the mitochondria, subsequently increasing susceptibility to the development both mood and neurocognitive disorders far after the stressor has been removed from the environment.